Uncoupling Oligodendrocyte Differentiation and Myelination: Axon Signaling Not Required

Project Summary/Abstract
Myelin is a crucial component of our nervous system. In the CNS, specialized cells known as oligodendrocytes
(OLs) differentiate from precursor cells (OPCs) and produce myelin by wrapping their plasma membranes
around axons. Myelin's main function is to insulate axons and allow for the fast conduction of electrical
impulses, and myelin damage as seen in preterm white matter injury and multiple sclerosis can lead to
permanent neurological disability. Currently no therapy exists for repairing this damage, but promoting OL
differentiation and myelination is a promising strategy. It is therefore important to understand how these
processes are regulated. My long term research goal is to understand the microenvironmental factors that
regulate OL differentiation and myelination. My short term goals are to (1) uncouple OL differentiation and
myelination and determine whether dynamic neuronal signaling has a role in regulating either process, and (2)
support a role for astrocytes in regulating OL differentiation. I will pursue my first aim in the lab of Dr. Jonah
Chan, an expert in neuronal-glial interactions, during phase I of the K22 award. To examine the role of dynamic
neuronal signaling I propose to completely eliminate it along the optic nerve by enucleating one eye of Wlds
mice. I will do this at two time points, an early time point to analyze OL differentiation and a later time point to
analyze myelination. I will also determine whether axon diameter is the main determinant of myelination by
performing enucleations in transgenic mice whose optic nerve axons are larger than normal (Pten cKOs). My
preliminary findings indicate that (1) OL differentiation and myelination are regulated by distinct mechanisms
and (2) dynamic neuronal signaling is not required for OL differentiation. For phase II, I will independently
investigate whether astrocyte factors whose transcription is upregulated during developmental OL
differentiation are sufficient and necessary to promote or inhibit OL differentiation. I propose to test sufficiency
in vitro using the BIMA screening assay where OPCs are isolated and seeded onto micropillar arrays then
treated with astrocyte factors to determine whether these proteins have an effect on OL differentiation. Then
CRISPR/Cas9 technologies will be used to specifically knock out the astroglial factors in vivo and determine
whether they are necessary for proper OL differentiation. I believe that these findings will uncover novel
regulators of OL differentiation, which could lead to myelin-promoting therapies. In order to successfully
achieve my research goals I will learn BIMA screening, electrophysiology, and astrocyte culture techniques
under the guidance of my sponsor, Dr. Chan and advisors during phase I. I will also become better trained in
crucial career development skills such as communication, leadership, management, and job interviewing skills
by participating in UCSF seminars and workshops during phase I. I am confident that this phase I training
along with the mentorship of my sponsor and advisors as well as the superior research environment at UCSF
will allow me to achieve my career goal of becoming an independent investigator at a top university.

Public health relevance
Project Narrative Myelin is important for proper nervous system function, however it is not clear how myelination and the differentiation of oligodendrocytes, the myelin-producing cells of the CNS, are regulated during development. My proposal seeks to 1) uncouple oligodendrocyte differentiation and myelination for the first time and examine the role of dynamic neuronal signaling in regulating both processes, and 2) support a role for astrocytes in regulating oligodendrocyte differentiation. My findings will help to uncover novel, OL differentiation regulators, which could lead to myelin-promoting therapies for the treatment of white matter injury and demyelinating diseases.